The effects of trauma-focused psychotherapy on reward circuitry function and information encoding

Project Summary/Abstract
The objective of this study is to identify how a trauma-focused psychotherapy for PTSD, cognitive processing
therapy (CPT), alters the function and information processing of the brain during reward learning. Preliminary
data indicate abnormal function of the brain’s reward circuit (ventromedial prefrontal cortex, ventral striatum)
during reward learning in PTSD. Changes in this circuitry may serve as one mechanism of therapeutic
improvement in diminished positive affect symptoms. This is an important area of study, as PTSD diminished
positive affect symptoms (e.g., difficulty experiencing positive emotions, diminished interest) are poorly
understood neurobiologically and consistently associated with poorer quality of life and worse clinical outcomes.
We will assess neural circuitry function and neural encoding (representation in brain signal) of reward-related
information parameters with functional magnetic resonance imaging (fMRI). Parameters will be derived from
reinforcement learning (RL) computational models of reward task behavior before and after CPT treatment.
Preliminary data indicate CPT alters the function and neural encoding of RL information parameters in PTSD,
and that changes vary by whether imminent threat is embedded in the reward processing context. This is an
ecologically valid approach to studying this construct, as: a) PTSD is characterized by hypervigilance for threat;
b) individuals with PTSD often perceive threat in the absence of explicit threat; and c) trauma-focused
psychotherapies utilize techniques that may impact both threat and reward-based processes. The rationale is
that improved understanding of therapeutic mechanisms may lead to identification of novel treatment targets,
which can be utilized to improve treatment outcomes. The central hypothesis is that CPT will alter neural
encoding of RL parameters during reward learning variably as a function of threat context. We will recruit 120
individuals with chronic PTSD. Individuals will undergo clinical and fMRI assessment to measure brain function
during reward learning with a contextual threat manipulation. RL computational models will facilitate examination
of neural encoding under contexts where threat is present or absent. Participants will then be randomized
(stratified on presence of comorbid major depressive disorder to ensure equal representation across arms) to
receive either immediate, individual CPT treatment or to a delayed treatment condition (N=60 each). Individuals
will then repeat clinical and fMRI assessments, and those in delayed treatment will then commence with CPT
treatment. It is predicted that CPT will: a) in the absence of threat, enhance neural RL encoding in the ventral
striatum and ventromedial prefrontal cortex and decrease neural encoding in the amygdala; and b) under threat
(of shock), promote a reduction in ventral striatal/ventromedial prefrontal RL neural encoding and an adaptive,
treatment-facilitated increase in dorsolateral prefrontal cortex RL encoding. Outcomes will enhance
understanding of trauma-focused psychotherapy mechanisms and may provide novel future treatment targets.

Public health relevance
Project Narrative Posttraumatic stress disorder (PTSD) is a prevalent and impairing mental health condition, and symptoms of diminished positive affect (e.g., difficulty experiencing positive emotions, diminished interest) are consistently associated with poorer quality of life and worse clinical outcomes. Cognitive processing therapy (CPT) is an evidence-based trauma-focused psychotherapy with abundant evidence of clinical efficacy, but the neurobiological mechanisms by which trauma-focused psychotherapies, such as CPT, promote improvements in symptoms of diminished positive affect are not at all understood. The long-term public health goal of this project is to identify how CPT promotes changes in the function and information processing of neural circuitry involved in positive affect using reward processing paradigms and brain imaging, which will serve to inform our understanding of existing efficacious trauma-focused treatments and provide new opportunities for improving PTSD treatment outcomes through targeting the neural mechanisms underlying this poorly understood symptom cluster.